Antibiotic tolerance by multidrug resistant uropathogenic Escherichia coli during quiescence

Project Summary / Abstract
Clinical uropathogenic Escherichia coli (UPEC) strains, which are the causative agent of most urinary tract
infections (UTIs), form quiescent intracellular reservoirs in the host where they can evade the action of
antibiotics. We recently found that many clinical UPEC isolates also enter a non-proliferative quiescent, but
viable, state in vitro that is quorum-dependent and reversed by specific signals, including peptidoglycan
fragments (1). Of the 145 UPEC strains tested, 51 entered quiescence in vitro (1), including the well-studied
virulent strain CFT073 and the pandemic strain JJ1886, a group B2 multi antibiotic resistant ST131/H30-Rx
blood isolate from a patient with fatal urosepsis. Here, we will determine if quiescent UPEC cells formed in vitro
are capable of evading antibiotics across major antibiotic classes as a result of entering the quiescent state.
Our in vitro model will lay the foundational groundwork to rapidly determine if a clinical UPEC isolate enters
quiescence and if so which classes of antibiotics are effective at killing those quiescent cells. We propose to
uncover the antibiotic tolerance features associated with quiescent UPEC and test strategies to induce
proliferation, which may overcome antibiotic tolerance.
In Aim 1, we will elucidate the bactericidal and bacteriostatic effects of major antibiotic classes on
growing and quiescent cells of clinically significant UTIs, including JJ1886, a multidrug resistant ST131
strain, and CFT073, an ST73 strain. We will determine if antibiotic tolerance is reversed upon stimulating
proliferation of quiescent cells by addition of external proliferation signals in vitro.
In Aim 2, we will test if UPEC cells become quiescent upon invasion of cultured epithelial cells and
if proliferants modify the antibiotic tolerance and susceptibility profiles of bacteria associated with
intracellular reservoirs.
SIGNIFICANCE: Most UTIs are caused by UPEC and many patients experience recurrent infections. The
bacteria associated with recurrent infections are thought to survive antibiotic treatment by entering a quiescent
state in bladder epithelial cells, which allows them to resume growth upon release into urine at a later time. The
studies proposed here are straightforward yet they may have significant implications for treating recurrent UTIs.
We will identify if quiescent UPEC cells have tolerances to specific classes of antibiotics, and susceptibility to
others, whether this translates to the same or different tolerances and susceptibilities in intracellular reservoirs,
and whether quiescent cell tolerance in intracellular reservoirs can be modified by addition of specific
proliferants. Therefore, the studies proposed here may elucidate new therapeutic strategies to prevent both
antibiotic tolerance in UPEC and recurrent UTIs caused by UPEC.

Public health relevance
PROJECT NARRATIVE Urinary tract infections (UTI) occur in approximately half of all women and the majority of infections are caused by strains of uropathogenic Escherichia coli. Here, we propose experiments to determine the extent to which uropathogenic E. coli is tolerant to antibiotic exposure while it is in a quiescent state in vitro and in cell culture- based infection assays. This research may lead to new treatment approaches for recurrent UTI infections even with multidrug-resistant strains.